Salmonella-mediated delivery of Francisella type VI secretion system proteins as antigens to induce protective immunity

PROJECT SUMMARY/ABSTRACT
Bacterial pathogens employ a myriad of mechanisms to invade the host, evade immune responses and inflict
damage. Arguably the most pathogenic bacterium known is Francisella tularensis, which boasts a mortality rate
upwards of 60%, is transmitted via aerosols, and can be made antibiotic resistant through rudimentary methods.
Based on these characteristics, F. tularensis is one of only three bacteria of highest concern for weaponization
by the Centers for Disease Control and Prevention. Although these bacteria have been studied since the early
1900s, we still lack a protective and non-toxic vaccine. These intracellular bacterial pathogens employ a
contractile toxin secretion apparatus called the type VI secretion system (T6SS) to inject effector proteins into
host cells to facilitate invasion into the cytosol and proliferation. Deleting any component of the T6SS apparatus
or the effector proteins that it secretes renders Francisella avirulent. In this application, we propose to use an
established antigen delivery strain of Salmonella to insert Francisella T6SS proteins directly into phagocytic cells
to induce protective immunity. The protective immunity enhanced Salmonella vaccines (PIESVs) are composed
of S. Typhmurium strains that simultaneously induce antigen expression and self-destruct within 8-10 cell
divisions in the host. This results in antigen delivery into phagocytic cells within lymphoid tissue and has been
used extensively as an antigen delivery platform. We will construct PIESV strains that express T6SS proteins
and determine if they can elicit protective immunity in a mouse model for Francisella infection. These studies
will provide insight into antigens that are protective against subsequent infection.

Public health relevance
PROJECT NARRATIVE Francisella are a group of remarkably virulent bacteria that have previously been developed as biological weapons, and we lack effective vaccines to mitigate the dangers they pose to public health. These bacteria rely on a protein secretion apparatus called the type VI secretion system (T6SS) to invade host cells and evade immune responses. In this project, we will use self-destructing Salmonella strains to deliver T6SS proteins into animals to determine if immune responses to T6SS proteins are protective against subsequent infection with Francisella.